Toward Personalized Prognosis and Outcomes in Primary Progressive Aphasia

Summary/Abstract
Primary progressive aphasia (PPA) is a devastating neurodegenerative syndrome that involves
relentless development of aphasia with relative sparing of other cognitive functions, at least
early in its course. There are multiple subtypes as well as multiple underlying pathologies. PPA
and its subtypes can be difficult to differentiate from other neurodegenerative disorders and
from each other, particularly early in their course. There are currently few clinical tools to assist
in the early specific diagnosis of PPA and its subtypes.
We have recently made substantial preliminary progress toward the development of novel
imaging techniques that could be extremely valuable in early specific diagnosis of the molecular
basis of specific pathologies underlying PPA. We propose to use tau and amyloid imaging
tracers to attempt to discriminate these underlying molecular pathologies, functional connectivity
MRI, diffusion tensor imaging MRI, and morphometric structural MRI to measure and
longitudinally monitor markers of neurodegeneration in the language network(s) and other brain
regions. In addition to more accurate diagnosis, these measures will likely be important for
prognostication and monitoring of decline and the effects of putative therapies.
The overall goal of this proposal is to translate these methods from new scientific technologies
into clinically useful tools that can be used by clinicians around the country and internationally to
improve the diagnostic specificity and assessment capabilities for PPA and its subtypes.

Public health relevance
Project Narrative Primary progressive aphasia (PPA), a devastating neurodegenerative syndrome that involves relentless development of language impairment, is currently not treatable in part because of a lack of tools available for identifying the underlying molecular diagnosis and for monitoring patients. This project aims to employ and validate new imaging methods for use as markers in clinical research and care, one goal of which is to serve as markers to determine whether potential therapies are effective.